Neuroprotection against Gulf War Illness by an alpha 7 nicotinic Acetylcholine Receptor modulator

Project Summary
More than 200,000 veterans of the 1st Persian Gulf War (1990-91) returned home with puzzling morbidity difficult
to diagnose and characterize called the Gulf War Illness (GWI). The main cause of the GWI was an unfortunate
combination of pyridostigmine bromide administered for prophylactic purpose against sarin in addition to DEET
and the insecticide permethrin for insect control. There is evidence that traces of sarin contributed to the severity
of GWI.
The objective is to develop a pharmacological therapy for GWI and identify signaling pathways altered by the
disease. To achieve that in a mouse model of GWI we will test the effectiveness of 4R-cembratrienediol (4R) to
stop the persistence of the GWI and its symptoms.
The hypothesis that drives this project is presented as three sub-hypotheses: 1) Characterization of a theater
reflective GWI animal model could reveal the mechanism of the disease. 2) After a period of exposure to the
neurotoxic compounds, the GWI does not lessen in intensity because damaged neurons release pro-apoptotic
signals that propagate the neuronal damage and induce inflammation. Inflammation is known to facilitate cellular
damage. Therefore, an ongoing neuroinflammatory cell-damaging cycle continues releasing pro-inflammatory
signals even after the influx of external neurotoxicants was terminated. 3) Modulation of α7 Nicotinic
Acetylcholine Receptor by 4R will inhibit the inflammatory signals, thus ceasing the damaging cycle.
We aim to strengthen an established GWI mouse model (10 days PB and PER) with DEET, traces of DFP (a
compound similar to sarin). The mice will be subjected to the GWI-like exposure for 12 days followed by a post-
exposure period where the detrimental behavioral effect will be assessed every 30 days and compared to
subjects exposed only to the vehicles. The variables tested will be closely related to the complaints from the GW
veterans – the presence of anxiety and memory impairment. Further, the neural injury will be evaluated by
morphological alterations, hippocampal cytokines, and the presence of ER stress.
Once the animals show GWI-like symptoms we will administer 4R neuroprotective treatment for 6 weeks. The
neuroprotective efficacy will be monitored by behavioral tests. After scarification, the tissue morphology, synaptic
integrity, and cytokine levels will evaluate the effect of 4R and vehicle-treated GWI and control mice. Upstream
and downstream 4R effect on chronic ER-stress and anti-apoptotic signaling pathways will be characterized.
The proposed experiments are a bold but nevertheless rational and realistic approach to the search for a
treatment to improve the health of veterans afflicted by GWI. When the present project is successfully
accomplished the next step should be to inquire with the FDA about the steps needed to obtain the IND status
for 4R and finally for clinical trials. This could change the paradigm of GWI treatment.

Public health relevance
Project Narrative The simultaneous exposure to Gulf War Illness (GWI) related chemicals is the cause of the multi-symptomatic disorder in GW veterans. However, the mechanism of the development of this neuroinflammatory disease remains obscure due to the complexity of the disease and the lack of a war theater reflective animal model. We propose to test a novel drug for the treatment of GWI which was successful in decreasing other brain pathologies.